Center for Dissemination and Implementation At Stanford (C-DIAS): Research Core

C-DIAS RESEARCH CORE: PROJECT SUMMARY/ABSTRACT
Improved access to evidence-based pharmacological and psychosocial treatments is urgently needed for
persons with substance use disorders. Inequity in access to proven treatments is amplified in low-resourced
communities and with organizations serving marginalized and underrepresented populations. The lack of rigor
and consistency in methods, measures, design and approach undermines efforts to systematically learn how to
implement evidence-based interventions across diverse settings. There is an enormous need for greater
precision in how to implement and sustain proven interventions for addiction. Interventions and their delivery
platforms are the “what” of an implementation endeavor, whereas implementation strategies are the “how”
these interventions are installed and/or maintained. Only 2.4% of NIDA-funded research has examined the
“how” of implementation strategies, and among these few, wide methodological variation exists. The Center for
Dissemination & Implementation At Stanford (C-DIAS) Research Core integrates three teams of experts, led by
top research scientists. The teams align with three domains necessary to advance implementation research in
addiction: Methods & Measures, Design & Modeling, and Policy & Financing. Three complementary and
innovative C-DIAS Research Projects will serve as open laboratories for Research Core activities. The Core
will interact bi-directionally with the Research Projects, positioning each to accumulate and disseminate
technical knowledge for the field. These synergistic efforts create an unprecedented opportunity for a deeper
and accelerated examination of the mechanisms underlying how implementation strategies work, their
contextual determinants, and how to select and deliver them to optimize implementation and clinical outcomes.
The three Research Core teams, along with the Research Projects, will translate options about how to
implement and at what cost for real-world decision-makers. The Research Core will: PREPARE the addiction
research and practice communities with pragmatic and standardized methods and measures of implementation
strategies for real-world implementation endeavors (Aim 1); IMPLEMENT rigorous examinations of the
components and mechanisms of implementation strategies for effectiveness and cost, using innovative
designs and modeling techniques, and creating decision-support tools for policymakers and systems leaders
(Aim 2); and, SUSTAIN and scale-up evidence-based addiction treatments by identifying barriers, needed
policy and financing strategies, and emerging solutions for ensuring their long-term, high quality and equitable
delivery in community settings and health systems (Aim 3). Research Core activities directly address NIDA
priorities to “better understand the barriers to successful and sustainable implementation of evidence-based
practices and to develop implementation strategies that effectively overcome these barriers.” Not incremental,
but instead paradigm shifting, the C-DIAS Research Core will add to the best of existing methodologies, and
advance generalizable and practical innovations to improve equitable access to proven addiction treatments.